Deciphering novel cell death mechanisms and metabolic reprogramming in response to microenvironmental stress.

Title: Deciphering novel cell death mechanisms and metabolic reprogramming in response to
microenvironmental stress.
Understanding how cells respond to microenvironmental stress is essential for unraveling fundamental
biological processes. While acute stressor perturbations in tissues are often transient, the cellular changes
induced can persist long after the initial stressor has subsided, challenging our current knowledge of long-
term impact of microenvironmental stress. My laboratory combines cell- and genome-engineering with
transcriptional, epigenetic, and metabolic profiling to understand cellular fate decisions informed by the
surrounding microenvironment. With these tools, we have revealed an unexpected phenomenon: Cells
exposed to immune cell activation can undergo cell death without specific antigen recognition, cytokine
signaling or apoptosis induction, suggesting the existence of a novel mechanism of cell death with far-reaching
implications for various biological processes. Our preliminary experiments provide a crucial insight: the
disruption of translation of mitochondrial respiratory chain genes confers resistance to this form of cell death
in exposed cells. This observation suggests that exposure to immune activation induces nutrient deprivation in
the surrounding microenvironment, forcing exposed cells to adopt alternative metabolic pathways for
survival. The absence of widespread tissue death during exposure to immune activation further supports this
hypothesis, indicating that surviving cells likely undergo significant metabolic reprogramming to adapt to
these challenging conditions. The research in this Maximizing Investigators' Research Award proposal aims to
capitalize on our deep expertise in cell engineering and metabolic profiling to (I) characterize the precise
mechanism of cell death in non-targeted cells exposed to immune activation and (II) elucidate the metabolic
and subsequent epigenetic reprogramming events occurring in surviving cells, along with their long-term
consequences in the contexts of wound healing, cellular senescence, and tissue homeostasis.
Understanding this novel cell death mechanism and its evasion through metabolic reprogramming has
the potential to revolutionize our comprehension of fundamental cellular processes. This knowledge could
have profound implications for diverse fields of cell biology, shifting paradigms in our understanding of how
cells respond to external stressors and commit to life-or-death fate decisions. Our findings may illuminate new
principles of metabolic plasticity and cellular adaptation, providing insights into the complex interplay
between metabolism, cell survival, and cell death pathways. Ultimately, this research will expand our basic
understanding of cellular homeostasis, stress responses, and tissue maintenance, contributing to the broader
knowledge base of cellular and molecular biology. These fundamental insights could inform future studies
across various biological disciplines, potentially opening up new avenues for exploring cellular behavior in
both normal and pathological states.

Public health relevance
Project narrative This research investigates a newly discovered phenomenon where metabolically active immune cells induce cell death in surrounding tissues, independent of traditional immune recognition mechanisms. By elucidating the underlying mechanisms of this process and exploring how cells adapt to survive in such environments, we aim to uncover fundamental principles of tissue homeostasis and cellular adaptation to stress. These findings could revolutionize our understanding of chronic inflammatory diseases, aging, and cancer, potentially leading to novel therapeutic strategies for a wide range of conditions that significantly impact public health.